Functional and antigenic evolution of SARS-related coronaviruses

PROJECT SUMMARY
SARS-related coronaviruses (also known as sarbecoviruses) circulate in bat reservoirs, but two human
spillovers in the past 20 years—SARS-CoV-1 in 2002 and SARS-CoV-2 in 2019—have caused globally
devastating outbreaks. The emergence of SARS-CoV-2 from a previously unknown bat lineage highlights the
pressing need to trace the evolutionary origins of viral properties that enable human spillover and develop
therapeutic reagents that can broadly inhibit infection by diverse, potentially unsampled sarbecovirus lineages.
Sarbecovirus zoonosis depends in part on the evolution of viruses to interact with ACE2 receptors on the
surface of human and potential intermediate hosts’ cells, mediated by the viral spike receptor-binding domain
(RBD). The RBD is also a key component to therapeutic control of SARS-CoV-2 and presumably other
sarbecoviruses, as it is the target of the most potently neutralizing antibodies, including those in clinical
development and in polyclonal human sera. Although I and others have begun surveying the impacts of
mutations within SARS-CoV-2 itself on important biochemical phenotypes including binding to ACE2 receptor
and antiviral antibodies, these studies have only limited utility in understanding the broader evolution of
sarbecovirus RBDs, which exhibit considerable divergence in sequence and function.
To characterize sarbecovirus functional and antigenic evolution, I propose to combine high-throughput protein
binding experiments with computational evolutionary analyses, functional virology, and biochemistry:
1. I will profile the ACE2-binding specificities of all known sarbecovirus RBDs and their evolutionary
precursors. I hypothesize that the ability to bind ACE2, including the human ACE2 ortholog, is more
evolutionarily and geographically widespread than previously appreciated.
2. I will systematically characterize how diverse RBD mutations affect ACE2-binding phenotypes. I
hypothesize that human ACE2 binding is an easily evolvable trait in sarbecovirus lineages where it has not
been previously considered. I also hypothesize that divergence among sarbecovirus lineages shifts the genetic
and biochemical determinants of ACE2 binding over evolutionary time.
3. I will identify RBD epitopes that are susceptible to broad pan-sarbecovirus antibody binding. By
determining the relationship between breadth and other antibody properties across RBD epitopes, I highlight
key features to target in the design of next-generation pan-sarbecovirus vaccines and antibody therapeutics.
Identification of the evolutionary and biochemical basis for key sarbecovirus features enhances viral
surveillance and therapeutic development, preparing for or even preventing future sarbecovirus spillovers. The
new experimental expertise, broader training and mentorship, and research systems developed in this work will
enable me to achieve my goal of leading an academic lab studying protein evolution at the host-virus interface.

Public health relevance
PROJECT NARRATIVE SARS-related coronaviruses circulate in bat reservoirs, but recent spillovers into human populations highlight the continued and hidden threat this diverse viral group poses for human health. This work identifies the evolutionary origins, geographic breadth, and biochemical determinants of key receptor-binding phenotypes that enable spillover, enhancing surveillance for lineages of spillover potential. Furthermore, this work identifies antibody epitopes that are susceptible to broad pan-sarbecovirus antibody binding, aiding in the design of therapeutic reagents and vaccines that can prepare for or prevent future spillovers from diverse, potentially unknown SARS-related coronavirus lineages.